Evolution on epidemiologically-relevant timescales

PROJECT SUMMARY
Genetic variation encodes the history of our species, underlies our ability to adapt to new environments, and is
the basis for individual- and population-specific disease risk. Over billions of years, evolution has transformed
living organisms from simple single cells to the huge diversity around us. However, evolution is more than an
ancient process of our past; it is ongoing. While a flash of evolutionary time, the last ~10,000 years have been
a period of extraordinary genetic and phenotypic change: humans have adopted agriculture, pushed into new
environments, and exploded in population size, increasing gene flow between populations and infectious
disease exposure. Indeed, most human genetic variants arose in the last 10s to 100s of generations. Yet,
many common population-genetic tools don’t work on this timescale. By leveraging the signatures of rapid
evolution, we aim to tackle fundamental evolutionary questions such as how populations adapt to new
environments and emerging diseases. Over the past 4 years since starting the lab and R35, we have
developed and applied multiple new theoretical models and computational methods to understand
demographic and selective processes in admixed populations. The flexibility of the R35 further allowed us to
branch into two newer models systems for evolutionary genetics: pathogen evolution and primates as a model
of human evolution. Over the next five years, we will tackle these questions across three timescales and model
systems. Area 1: leveraging genetic ancestry to infer adaptation & phenotype evolution. We will develop new
statistics to infer positive selection within the last tens of generations using admixed genomes both before and
after admixture, and use ancestry patterns to test hypotheses about broader genetic architectures. Area 2:
model-based inference of selection under complex pathogen lifecycles. Using our expertise in population-
genetic and dynamical systems transmission models, we recently developed a model that bridges
epidemiological and genetic change by synthesizing whole-genome simulations and dynamical systems
models. We will extend our theoretical models of evolution in pathogen systems that incorporate realistic
dynamics, starting with malaria as a case study, to understand how different aspects of the lifecycle shape
neutral variation and our ability to detect adaptation. Finally, Area 3: using primates as a model of large-scale
structural evolution. As our close phylogenetic relatives, primates are an ideal system to understand human
evolution, and mechanisms generating genetic variation. Within mammals, large-scale structural variation and
chromosome number evolution is generally one of the slower evolutionary processes with large conservation
across phyla. However, multiple primates show surprisingly large karyotype evolution and structural changes
during within-genus radiations. We will use a combination of population-level resequencing of wild primates
with long-read technologies to study karyotype evolution, recombination variation, and the potential adaptive
consequences of structural variation.

Public health relevance
PROJECT NARRATIVE Most human genetic variants arose in the last 10s to 100s of generations. Yet, many common population- genetic tools don’t work on this timescale. We develop new tools that leverage patterns of ancestry in humans, structural variants in our primate relatives, and lifecycle dynamics in pathogens.